Cross Training Core

PROJECT SUMMARY
Cross-Training Core
Cancer is a major public health problem worldwide and is the second leading cause of death in the US.
Advances in our understanding of the biology of cancer have the potential to lead to significant breakthroughs
in cancer diagnosis, detection, and treatment. However, the translation of basic science discoveries to clinical
advancements has been slow and inefficient. The translation of molecular insights from the lab to clinical trials
and ultimately to clinical practice relies on the close collaboration of scientists (radiation biologist and medical
physicist) and physicians (radiation oncologist) with diverse training backgrounds. A major barrier to the
integration of these basic scientists and physicians in translational settings is the lack of enhanced mentored
training opportunities focused on radiation biology workforce development. To address the urgent need for
well-trained independent investigators in cancer research who can bridge the gap between scientific discovery
and clinical advancement, we propose the Cleveland Clinic Foundation (CCF)-Emory Cross-Training Program
in ROBIN that will take advantage of the outstanding resources, high caliber of investigators, and close
collaboration between cancer biologists, clinicians and physicists at the Cleveland Clinic Case Comprehensive
Cancer Center and Winship Cancer Institute of Emory University. The CCF/Emory Cross-Training Core will
provide a unique, individualized, and multi-faceted cross-training experience to support the development of
trainees (PhD and/or MD) in acquiring the knowledge and skills to address the most important biological
questions and clinically significant problems so that they can make transformative discoveries to improve
quality of care for patients with cancer. The primary objective of the Cross-Training Core is to develop and
sustain a collaborative environment that encourages the center membership to increase interactions, sharing,
and rapid adoption of concepts and approaches. The cross-training core will establish and accelerate
advances from projects to paradigms by providing training and expertise with an overall trajectory that
promotes wider adoption by the oncology community to improve patient outcomes. We will operationalize the
mission of the cross-training core through integrated training opportunities for radiation biologists, medical
physicists, and radiation oncologists with the goal of engaging trainees in research across the ROBIN Center’s
multiple cores and projects. Building on a strong existing culture of education and training, we propose the
following specific aims: (1) Develop a centralized radiation biology integration network to facilitate scientific
cross-pollination between radiation oncology, radiation biology, and medical physics within the ROBIN Center;
(2) Disseminate clinical / translational data from Cores, Projects, and Molecular Characterization Trials across
the center with the broader mission of fostering cross disciplinary training and collaboration; (3) Develop a
ROBIN center wide workforce development program relying on interdisciplinary training for clinicians,
physicists and radiation biologists in translational radiation biology.